Systematic Light Exposure Intervention for Fatigue and Cognitive Efficiency in Pediatric Brain Tumor Survivors

PROJECT SUMMARY/ABSTRACT
Due to advances in detection and treatment, there is a rapidly increasing population of survivors of pediatric
brain tumor. With increased survival rates, there is greater emphasis on managing the late effects of pediatric
brain tumor. Cognitive symptoms are prevalent among survivors and are associated with poor academic
achievement, vocational success, and overall quality of life. However, few interventions have been trialed to
reduce cognitive symptoms. To this end, fatigue is a common late effect of brain tumor and its treatment, and it
significantly reduces cognitive efficiency, including attention and speed of processing information. Among
survivors, interventions that are low cost, non-pharmacological, and appropriate for self-management are
highly desired but rare. Systematic bright light exposure has been shown to be effective for improving sleep
and reducing fatigue among adolescent and adult patient populations, including adolescent and young adult
solid tumor, and adult cancer survivors. The purpose of the proposed study is to evaluate the feasibility and
preliminary effectiveness of systematic bright light exposure for reducing fatigue and improving cognitive
efficiency among pediatric brain tumor survivors. Forty survivors (ages 10-18 years) will be asked to wear
systematic light exposure glasses for 30 minutes upon awakening for a six week period with follow-up at 2-
weeks post-intervention. Systematic bright light exposure (intervention) will be compared to dim light exposure
(placebo-control). As part of this study, we focus on intervention fidelity, using an integrated app recording
timing and duration of light exposure; and adverse side effects associated with light exposure. We assess
preliminary outcomes associated with patient and parent-proxy reports of fatigue and cognitive efficiency using
in-person and remote administration of a computerized battery. The ultimate goal of this line of research is to
trial interventions that mitigate cognitive late effects to improve quality of life in pediatric brain tumor survivors.
Findings from this pilot study will be used to refine the intervention and inform a larger randomized controlled
trial.

Public health relevance
PROJECT NARRATIVE Survivors of pediatric brain tumor often experience late effects of treatment including symptoms of fatigue and reduced cognitive efficiency that ultimately have adverse effects on health-related quality of life and other functional outcomes such as academic achievement and vocational success. There are few, well-researched interventions aimed at mitigating the effects of cognitive late effects on functional outcomes in this highly at risk population. The goal of this proposal is to evaluate the feasibility and preliminary effectiveness of systematic light exposure on reducing fatigue and improving cognitive efficiency in survivors of pediatric brain tumor, and these findings will be used to inform a full-scale randomized controlled trial to examine the efficacy of this intervention and the mechanisms supporting it.